High Performance Text Mining for Translator

We propose to build a knowledge provider that will seek out, integrate and provide AIready,
BioLink-compatible models via high-performance text-mining of the biomedical literature.
Problems with Translator’s current mining of the biomedical literature that we intend to
solve include: (1) weaknesses in framework extensibility and benchmarking that make
integrating and validating new text-mining approaches difficult; (2) problematic licensing of
software, terminologies and other resources that do not adequately support FAIR (and TLC)
best practices; (3) processing only PubMed titles and abstracts, not full text publications; (4)
Translator’s use of older NLP technology with relatively poor performance; (5) lack of a
mechanism for community feedback regarding errors and other problems; (6) lack of continuous
updates to add knowledge from new publications; (7) output knowledge representation that is
simplistic and vague, failing to reflect the richness of what is expressed in scientific documents.

Public health relevance
No Text